Statistical Methods for Precision Environmental Health with Mixture Exposures

Project Summary/Abstract
Precision environmental health focuses on individual risk assessment to inform targeted disease prevention strate­
gies. Identifying individuals with increased sensitivity to environmental exposures is especially challenging with
mixture exposures. The health effects of exposure to mixtures are likely to depend on the composition of the
mixture, characteristics specific to the espoused individual including individual­ and neighborhood­level factors,
and the developmental stage at which an individual is exposed. We propose to develop statistical methods for
precision environmental health with mixture exposures. The proposed methods will estimate mixture­exposure­
response relationships that are individualized based on multiple candidate modifying factors. The framework we
develop will allow for data­driven discovery of novel combinations of individual­ and neighborhood­level factors
that define susceptible subgroups. We will address three specific data settings. In Aim 1 we propose a general
framework for effect heterogeneity using established mixture methods including Bayesian multiple index models.
This will include heterogeneous versions of Bayesian kernel machine regression and linear index models. In Aim
2 we develop methods to identify critical windows of susceptibility to mixtures that are assessed longitudinally.
The methods will allow for identification of individualized windows of susceptibility to a mixture and estimation of
individualized mixture­exposure­time­response functions. In Aim 3 we develop heterogeneous mixture methods
for multiple outcomes. The multiple outcome methods will apply to trajectories defined by repeated measures of
common endpoint or pathway as well as shared information across multiple related endpoints, such as multiple
measures of a common pathway. In Aim 4 we will develop software to implement the methods, along with vignettes
and tutorials. We will use the methods developed to analyze air pollution mixtures in a large administrative birth
cohort and in a Northeastern United States longitudinal perinatal cohort drawing from multiple source populations.
We will estimate individualized mixture­exposure­response functions for birth weight and multiple neurodevelop­
mental endpoints assessed at multiple times. The methods we develop will allow for new avenues of precision
environmental health to better identify individuals at increased risk of adverse effects of the environment, which
will better inform targeted disease prevention strategies.

Public health relevance
Project Narrative We will provide first of its kind methods to estimate health effects of environmental mixtures that account for ef fect heterogeneity driven by multiple individual and neighborhood level modifiers. The new methodology will advance precision environmental health research and identify individuals with increased sensitivity to environ mental mixtures. Freely available software and vignettes will make the methods available to the wider scientific community.